Early hematoma lysis and hemoglobin toxicity in intracerebral hemorrhage

ABSTRACT
There is much evidence that the hemoglobin released after erythrocyte lysis is a cause of brain
injury after cerebral hemorrhage. This may be related to hemoglobin or its degradation products
(e.g. iron). How to reduce such injury is important considering there are no current clinically
proven therapies for intracerebral hemorrhage. One mechanism that is involved in limiting
hemoglobin toxicity systemically is CD163, a hemoglobin scavenger receptor, which is involved
in the cellular uptake of hemoglobin when bound to haptoglobin. However, in cerebral
hemorrhage, our recent results, supported by others, indicates that some hemoglobin is
released before CD163 and other defense mechanisms are upregulated in brain (early
erythrolysis). In addition, while microglial CD163 may be beneficial in scavenging hemoglobin,
CD163 is also upregulated in neurons and is involved in inducing cell death. The aims of this
proposal are, therefore: 1) Determine the mechanisms by which early hemoglobin release from
cerebral hematomas occurs and can be reduced. 2) Examine whether CD163 is a therapeutic
target in intracerebral hemorrhage. 3) Determine the mechanisms regulating CD163 in
microglia and neurons in order to potentially manipulate those levels independently. These
experiments will involve in vivo and in vitro models of intracerebral hemorrhage in rats, mice and
pig already established in our laboratories.

Public health relevance
NARRATIVE Cerebral hemorrhage is a devastating form of stroke with high mortality and most survivors having long-term disability. Currently, there are no therapies for intracerebral hemorrhage. Brain injury is related to the release of hemoglobin from the hemorrhage into surrounding brain and this proposal seeks to control that release and determine methods of limiting hemoglobin- induced injury.